RNA binding proteins in atherosclerosis

PROJECT SUMMARY
Regulation of RNA biogenesis and turnover is central to the maintenance of cholesterol homeostasis and
atherosclerosis development. More recently, we have come to appreciate that chemical modifications on
RNA can profoundly dictate transcript fate. N6-methyladenosine methylation (m6A) is the most common RNA
modification in mammalian cells. It is now established that m6A plays a critical role in cellular differentiation,
organismal development, and cancer transformation. However, there is limited knowledge of the impact of
RNA modifications on atherosclerosis pathways. The overarching goal of this proposal is to define the role
and mechanisms of chemical modifications on RNA in atherosclerosis. Our recent studies and other
abundant preliminary data, nominate m6A as a critical modulator of atherosclerosis risk factors and lesion
development. In aim 1, we use genetic perturbations and vector-transduced models to investigate the
importance of m6A in the control of serum cholesterol, and low-density lipoprotein uptake and test an RNA
modification-based therapeutic strategy. In aim 2, we define how m6A in myeloid cells regulates cellular
responses within lesions. Our assembled group of multidisciplinary scientists will work together to investigate
this new layer in gene regulation. We anticipate that our proposed studies will provide important insights as to
how RNA modifications impact cardiovascular health and disease and offer a provocative framework for new
avenues in mitigating heart disease.

Public health relevance
PROJECT NARRATIVE The RNA molecule carries critical information that is essential for health and often affected in disease states. We now appreciate that adding a chemical modification on RNA can impact its fate, and this proposal will test how chemical changes on RNA influences heart disease. This proposal will improve our understanding of what goes wrong when atherosclerosis develops and offer potential new targets for heart disease mitigation.